Lipid Bilayer Remodeling and Protein Intermediates During Membrane Fusion

Protein-mediated membrane fusion is essential for a multitude of fundamental biological processes. Despite
intensive study, at present we have a limited mechanistic understanding of how fusion protein machinery
manipulates lipid membranes in order to induce their fusion. This lack of knowledge is particularly acute regarding
the structure of membrane intermediates, the extent to which their leaflets are bent or disrupted into nonbilayer
structures, and how they are coordinated and remodeled by fusogens. Similarly, in terms of the structure of the
fusion proteins themselves, very little structural information is available to describe how they change as they
drive membrane fusion. These are processes that are targeted by therapeutics such as fusion inhibitors or
neutralizing antibodies in the case of preventing virus infection, and they are processes that can go awry as a
result of disease mutations for cellular fusogens. The proposed studies will expand our understanding of these
fundamental processes and reveal general principles employed by divergent fusion machines. Cryo-electron
microscopy and structural mass spectrometry provide powerful complementary methods to directly image and
probe membrane fusion because they allow us to trigger a fusion reaction under native conditions then trap and
then image or analyze intermediate states over the course of the reaction. Cryo-electron tomography in particular
can resolve individual fusion machines and membrane leaflets captured in the process of fusing and can discern
when the proteins and membranes have adopted non-canonical intermediate structures. Hydrogen/deuterium-
exchange mass spectrometry complements cryo-EM by enabling us to monitor local backbone dynamics under
native conditions. This approach is particularly effective for tracking conformational changes and for comparing
protein structure in different states. Building on our work with influenza virus, we will apply these methods to
investigate pathways of membrane fusion in two Class I viral fusion systems: the Env fusion protein used by HIV
and the S spike protein used by SARS-CoV-2. These fusion machines employ sequential modes of activation
and triggering involving receptor priming followed by either coreceptor binding (Env) or a proteolytic cleavage
event (S). These systems thus offer the opportunity to analyze in detail the fusion system arrested at an
intermediate, primed stage. For each of these systems, our goal is to image the architecture and progression of
membrane remodeling leading to formation of fusion pores and to understand the means by which the protein
machinery induces two separate membrane bilayers to join into one. By performing such an analysis, we will
gain novel insight into general, obligatory events in Class I protein-mediated membrane fusion, while also
revealing system-specific mechanisms. Our study should thus advance our structural and mechanistic
understanding of the fundamental process of biological membrane fusion while also providing valuable insight
into the mechanism of host invasion by two viruses that have ignited major pandemics impacting global health
and society.

Public health relevance
NARRATIVE Protein-mediated membrane fusion is a fundamental process that is essential for biological functions as wide ranging as gamete fertilization, formation of placenta, synaptic vesicle trafficking, tissue development, mitochondrial function, and enveloped virus infection. Despite its significance, relatively little is understood at a mechanistic and structural level regarding how specialized fusion protein machinery and membranes interact in order to go from a prefusion to activated fusogenic to the final formation of a fusion pore. Here cryo-electron microscopy and structural mass spectrometry will be used to study membrane fusion in two biomedically important enveloped viruses, thus providing new insights into how very different protein machines accomplish similar physical functions of merging two distinct membranes into one.